Endothelial cell senescence and APOE4 in vascular cognitive impairment and dementia

PROJECT SUMMARY/ABSTRACT
MAYO CLINIC JACKSONVILLE
Impairments of cerebral blood supply and blood-brain barrier (BBB) integrity cause neuronal damage, synaptic
dysfunction, and white matter injuries, which eventually lead to the pathogenic condition referred to as vascular
cognitive impairment and dementia (VCID). Importantly, aging is a strong risk factor for the disease
pathogenesis. In general, aging is predicted to be caused by accumulation of senescent cells, in which the
increase of p16INK4a is one of the key mechanisms triggering cellular senescent phenotypes. Thus, the major
goal of our project is to define molecular mechanisms in which cerebrovascular senescence to the pathogenic
pathways of VCID using mouse models. Apolipoprotein E (apoE) isoforms are also critically involved in the
cognitive decline seen in the elderly. While APOE4 is the strongest genetic risk factor for late-onset
Alzheimer’s disease, APOE4 increases the risk for mild cognitive impairment and VCID. Furthermore, APOE4
also causes neurovascular dysfunction, including BBB breakdown and the reduction of small vessels.
Therefore, we hypothesize that p16INK4a expression in endothelial cells triggers vascular senescence which
disturbs the homeostasis of the cerebrovascular system during aging, resulting in VCID and that APOE4
exacerbates VCID phenotypes. To reach our goals, we propose three specific aims. In Aim 1, we will
determine the impact of adeno-associated virus (AAV)-mediated p16INK4a expression in cerebrovascular
endothelial cells on VCID-related phenotypes in apoE3-tareget replacement (TR) and apoE4-TR mice. We
have found that cerebrovascular endothelial cell senescence induced by transient p16INK4a expression through
AAV leads cerebrovascular dysregulation in young wild-type mice. In Aim 2, we will examine how systemic
endothelial cell-specific expression of p16INK4a in conditional mouse models affects VCID-related phenotypes
depending on APOE4, accompanied with cerebrovascular single cell RNA-sequencing. In Aim 3, we will
examine the effect of senolytics on APOE4- and/or endothelial p16INK4a-mediated VCID-related phenotypes to
investigate the contribution of senescence in the AAV-based mouse and the conditional mouse models.
Collectively, these studies should provide novel insights into the cellular and molecular mechanisms that
underlie VCID pathogenesis.

Public health relevance
PROJECT NARRATIVE MAYO CLINIC JACKSONVILLE Aging-related disturbances in cerebral blood supply and blood-brain barrier (BBB) integrity leads to neuronal damage and white matter lesions, which often results in cognitive decline known as vascular cognitive impairment and dementia (VCID). APOE4 significantly exacerbates cerebrovascular pathology and the cognitive performance of the elderly. Since p16INK4a triggers cellular senescence during aging, we will comprehensively examine how endothelial cell senescence induced by p16INK4a contributes to the pathogenesis of VCID and how APOE4 modulates the mechanisms using mouse models.